Developing Real-time Interaction and Motion Tracking in Immersive Virtual Reality for Telerehabilitation

Abstract Unceasing breakthroughs in technology will shape future healthcare diagnosis, treatment, and delivery. Telerehabilitation delivers rehabilitative healthcare remotely to overcome spatial, temporal and economic barriers. Effectiveness of telerehabilitation has been seen for patients with orthopedic and traumatic injuries, degenerative central nervous system disorders, and cardiovascular diseases. With the globally growing population of chronically ill and disabled elders, telerehabilitation is in ever growing demand. However, the current telerehabilitation methods are predominantly based on audio/video interaction without objective measure of motor functions. This limitation prevents the delivery of precision medicine and largely constrains the efficacy and potential of telerehabilitation. A patient- and therapist-facing technology solution developed by MoVE, LLC, is described, and with proposed advancement is positioned to dramatically shift the current telerehabilitation diagnosis and intervention paradigm. Specifically, motion tracking is merged with 3D immersive virtual reality (VR) to render real-time user interaction and simultaneous motion tracking and analysis in the immersive VR and real environments. MoVE’s software interfaces with wired/wireless hardware motion sensors and a 3D VR headset for easy deployment at home or clinic. In our proposed Phase I STTR work, MoVE will collaborate with interdisciplinary university-based experts to achieve three aims in preparation for Phase II validation and commercialization. Aim 1 cross validates the precision of motion data captured in VR by introducing wireless optical motion sensors and validating them against the existing wired magnetic motion sensors. Aim 2 builds and tests the network code for remote data transmission and interaction via Internet Protocols, which will optimize remote delivery even in low internet speed/connectivity locations. Aim 3 engages physical therapists serving as pseudo- patients/-therapists in the design, development, implementation, and testing of a telerehabilitation diagnostic and therapeutic VR interaction task. Aim 1 and 2 outcomes are requisite to generating the minimally viable product (Aim 3) that is central to further therapist-informed development of applications and specific diagnostic and treatment telerehabilitation exercises (gaming-like activities). The ultimate goal is a patient-centered VR-based interactive telerehabilitation system with augmented feedback and tele-presence of a therapist. The proposed work will lay a foundation for a Phase II technology optimization via multi-site clinical trials. Ultimately, a commercial deployment will be made to penetrate the exploding telehealth market and health disparities will be minimized by virtue of this product serving people with constrained access to clinics and rehabilitation services.

Public health relevance
Project Narrative Telerehabilitation delivers rehabilitative care remotely to overcome spatial, temporal and economic barriers, but the precision of mainstream audio-/video-based telerehabilitation is constrained by the absence of accurate motion tracking and analysis. MoVE LLC is collaborating with university experts to advance a paradigm-shifting patient- and therapist-facing telerehabilitation technology that merges simultaneous wireless motion tracking and analysis in the 3D immersive virtual reality and real-time environments. The proposed innovation facilitates precision diagnosis and therapeutic rehabilitation, and with subsequent Phase II technology optimization and multi-site clinical trials, will lead to a commercial deployment penetrating the exploding telehealth market and minimizing health disparities by virtue of the technology serving people with constrained access to rehabilitation services and clinics.